CureGN

ABSTRACT
Cure Glomerulonephropathy Research Network (CureGN) is an international multi-center National Institute of
Diabetes and Digestive and Kidney Diseases (NIDDK)-funded observational study of patients with minimal
change disease, focal segmental glomerulosclerosis, membranous nephropathy, or Immunoglobulin A (IgA)
nephropathy, with the goals to improve understanding of these conditions and outcomes for patients. Since
2014, CureGN has enrolled over 2600 patients at more than 60 clinical sites. A wide range of clinical data are
collected to characterize disease course, treatment, and key outcomes at enrollment, three times yearly for the
first 3 study years, and twice yearly thereafter. To collect these data, coordinators navigate the clinical record
to locate information, enter it into the study's web-based data entry system (ArborLink), and respond to queries
on a quarterly basis, oftentimes requiring re-opening of the clinical record. Given the near-universal adoption of
electronic health records (EHR) and recent advances in health care information technology, opportunities to
leverage EHR extraction for data collection present an important opportunity for CureGN to transition to a more
modern chort study. Despite its potential, harmonization of EHR data across multiple institutions into curated
research data sets has significant challenges. New mobile health technologies allow patients to share their
data directly with researchers, seamlessly integrating EHR data from multiple health systems into a single data
source. In addition, other study data collection activities such as survey and validated patient reported outcome
administration can be assessed directly through the same application. This technology has been applied in
large studies such as the NIH-funded All of Us and holds great potential for remote data collection in CureGN.
This pilot study will (1) demonstrate the feasibility and scientific utility of EHR data sharing using the
MyDataHelps mobile application and (2) identify priority targets for application functionality in both data
collection and participant engagement in future CureGN studies. The pilot study will be implemented at four
CureGN sites, one from each Participating Clinical Center (PCC). Standard data quality checks will be
implemented and comparisons to manual data collection and entry into ArborLink will be made to assess
reliability of EHR data collection through this method. Finally, the pilot study team will engage with
stakeholders including site investigators, study coordinators, and research participants to assess how this type
of mobile technology can be leveraged across the network in the future. The timing of the pilot study and
preparation of a full consortium roll-out plan are critical to the successful continuation of CureGN.

Public health relevance
LAY NARRATIVE The Cure Glomerulonephropathy Network (CureGN) is a multi-center international consortium with the goal to increase understanding of and outcomes for patients with one of the following four kidney diseases: minimal change disease, focal segmental glomerulosclerosis, IgA nephropathy, and membranous nephropathy. CureGN has gathered data from over 2600 patients, since 2014, by manual collection of clinical data elements into a web-based data entry system by a coordinator at each study site. To improve efficiency, this study's two goals include (1) to pilot the collection of clinical data directly from a mobile application that allows patients to share their electronic heath record, and (2) to gather feedback on the use of mobile technology for data collection and participant engagement across the CureGN consortium in the future, with the aim toward long- term sustainability as a resource for the community.